Smart ventilated cage systems for next-level experimental design and monitoring of specialized animal models.

PROJECT SUMMARY
Murine models play a key role in a broad range of research areas given their comparable physiology to
humans and other mammals, known genetic backgrounds, and the ease of their housing and maintenance.
However, as we have gained a greater understanding of physiology, there has been a drive to create more
sophisticated models that better represent human disease progression and response to treatments. This has
led to the generation and use of mouse models with unique genetic backgrounds, behaviors, or susceptibility to
diseases. While these models have been of enormous value, they require regular monitoring and may need
special housing conditions (such as altered light/dark cycles) to maintain their health and successfully carry out
needed research. Incorporating this monitoring adds significant operational burden on facility staff and
researchers, and may also add to animal stress. Furthermore, even with increased physical monitoring of mice,
important changes in health status can be missed during non-observational periods, making this a challenging
problem to address.
To address these issues, the Institute of Comparative Medicine (ICM) at Columbia University Irving Medical
Center will acquire and install Tecniplast Digital Ventilated Cages (DVC) and Rack Environmental Monitoring
modules for its specialized animal resources. The features of the DVC system will improve ICM operations by:
1) Providing automated, 24/7 remote monitoring of various parameters linked to animal welfare and
environmental conditions of the animal facility; 2) triggering of automated alarms in particular conditions
requiring immediate attention (e.g., decreased spontaneous mouse activity, water flooding, limited water bottle
or food availability); 3) setting specific light/dark cycle for individual cages with the use of LEDDY units; and 4)
reducing the number of cage changes needed in some circumstances (e.g. single-housed mice), reducing
bedding waste.
Implementation of DVC cages will be targeted toward specialized shared resources that utilize the most
complex disease models, which will lead to a disproportionately large impact on animal welfare, facility
operations, experimental capability of researchers, and the reproducibility and rigor of research within ICM.

Public health relevance
PROJECT NARRATIVE Mouse models of cancer, infection, genetics, and behavior have become increasingly complex as researchers have sought to better understand disease biology and preclinical prevention and treatment strategies. These models require regular monitoring to ensure they remain healthy and accurately model disease and treatment responses. Installation of Tecniplast Digital Ventilated Cages will provide automated 24/7 monitoring of specialized room and cage parameters at CUIMC, thereby improving operational efficiency, reducing labor needs, and optimizing experimental design and animal health.